Identification of AMD3100 (Plerixafor) as a potential lead compound for chlorine toxicity

PROJECT SUMMMARY/ABSTRACT
Statement of problem: Chlorine (Cl2) gas is the most common inhalational irritant in the United States, which
results in serious adverse effects including lung injury and death. Previous studies by the PI and others have
demonstrated that migration and homing of leukocytes (neutrophils and macrophages) into lungs play a critical
role in lung morbidity and mortality post Cl2 gas exposure. The binding of the chemokine ligand, stromal-
derived-factor-1 (SDF-1), to the C-X-C chemokine receptor type 4 (CXCR4) on lung immune, epithelial, and
endothelial cells promote the migration of leukocytes from the circulation to lungs. The SDF-1/CXCR4 axis also
propagates the activation and survival of leukocytes in the lungs. Our preliminary data shows that both SDF-1
and CXCR4 levels are elevated in the lungs of Cl2 exposed animals. Therefore, our hypothesis is that SDF-
1/CXCR4 axis is involved in the migration, homing, and survival of leukocytes in lung post exposure to Cl2 and
therefore inhibiting this axis by an FDA approved compound, AMD3100 (Plerixafor), would attenuate Cl2-
induced lung morbidity and mortality. Specific aims: 1) Establish the role of SDF-1/CXCR4 axis in Cl2-induced
lung leukocyte migration, activation, and survival. 2) Optimize the dosage regimen of AMD3100 for Cl2 toxicity.
3) Delineate the mechanisms of SDF-1/CXCR4 regulation post-Cl2 exposure. Experimental approach:
C57BL/6 mice will be exposed to Cl2 gas (500ppm, 30min) and then the SDF-1 concentration in
broncholaveolar lavage fluid and the CXCR4 surface expression on the alveolar leukocytes and whole lung
tissue will be measured over time. It will also be analyzed whether, the SDF-1/CXCR4 axis mediates Cl2
dependent migration, activation, and survival of lung leukocytes. Next the Cl2 exposed mice will be
administered a clinically safe dose (0.01-0.16 mg/kg) of AMD3100 intramuscularly and the indices of acute and
chronic lung injury and mortality will be measured. Finally, the role of Cl2-induced hemolysis and hypoxia in the
regulation of lung SDF-1 and CXCR4 levels post Cl2 exposure will be studied in vitro and in vivo. Anticipated
results: We anticipate that AMD3100 will attenuate leukocyte translocation to lungs and subsequently mitigate
lung injury and improve survival in mice exposed to Cl2. Innovation: The study is the first to propose the use of
a novel, FDA-approved, small molecule compound, AMD3100, to mitigate lung injury and mortality post
exposure to Cl2 gas. AMD3100 may be beneficial in mitigating lung injury post exposure to other toxic gases
such as bromine and phosgene, which are also associated with hemolysis and increased migration of
leukocytes into lung.

Public health relevance
PROJECT NARRATIVE Exposure to chlorine (Cl2), a highly toxic gas, causes widespread damage to the lungs leading to acute lung injury, respiratory failure, and death at higher concentrations. However, there is no FDA approved countermeasure for Cl2 toxicity. This study proposes to determine if Plerixafor, an FDA-approved compound, can be used to mitigate lung injury and improve survival post Cl2 gas exposure.